Developing methods for high-throughput deep characterization of extracellular RNA, DNA, and vesicles in body fluids

PROJECT SUMMARY
Cell turnover and active secretion release extracellular (also so-called cell-free) RNA, DNA, and vesicles into
circulation. The presence of these extracellular analytes in bodily fluids has enabled broad applications in
oncology, transplantation, obstetrics, and metabolic and neurological degenerative diseases. Analyzing cell-free
DNA (cfDNA), cell-free RNA (cfRNA), and extracellular vesicles (EVs) provides clarity in understanding disease
states for clinical management. Major technical challenges in cfDNA, cfRNA, and EV analyses are associated
with their complexity, low abundance, and preanalytical variation. My lab develops new tools to address these
challenges in high-throughput deep characterization of cfRNA, cfDNA, and EVs in bodily fluids. First, we will
develop tools to reliably decompose and control for technical variability, RNA degradation, and complexity of
cfRNA. To address technical variability, we will identify an intrinsic cfRNA reference gene set using non-negative
matrix factorization. To reliably determine the cell-type-specific footprint of cfRNA, we will develop a k-mer-based
classification at the individual sequencing read level, leveraging highly abundant and commonly expressed
genes. To overcome the fluctuation and a high dropout rate caused by cfRNA low abundance and degradation,
we will build a computational framework for anomaly detection and biomarker combination using topic modeling.
Second, we will introduce a new method to induce the epigenetic contrast of cell-free nucleosomes (cf-
nucleosomes) directly in body fluids through polyamine-mediated phase separation. We aim to measure and
map cf-nucleosome pseudo-accessibility at sites that differ for cell states such as active and repressive
chromatin marks, transcription factor binding sites (TFBSs), regulatory loci, gene bodies, and 3D genome
structure. Third, we will develop a new technique to dissect the heterogeneity of EVs at the single vesicle level
using proximal barcode transferring. To enhance barcode transferring efficiency, we propose using bridge
amplification and DNA walking. To improve background correction and address the scarcity of proteins detected
on individual EVs, we will develop a computational framework utilizing an innovative mixture model approach
that accounts for noise and is robust against measurement dropout. In summary, we are developing methods to
analyze low-abundance
and
complex
circulating cfRNA, cf-nucleosomes and EVs in accessible bodily fluids. Our
non-invasive approaches will enable the investigation of natural longitudinal disease progression and adaptive
responses to interventions in human, non-human primates, and animal models.

Public health relevance
PROJECT NARRATIVE Analyzing accessible bodily fluids enables the investigation of natural longitudinal disease progression and in response to interventions in human, non-human primates, and animal models. We aim to develop new liquid biopsy approaches with capabilities to capture the alternations in diseases and treatment-induced responses at the phenotype level. We will develop technologies to deeply analyze cell-free cell-free RNA, extracellular vesicles, and epigenetics and dissect the heterogeneity of these liquid biopsy analytes.